CADENCE - Continuous And Data-drivEN CarE

ABSTRACT
Maternal opioid use disorder (OUD) is the leading cause of maternal mortality in the first year after delivery
nationwide. OUD also contributes substantially to out-of-home placements in the child welfare system.
Medication for OUD (MOUD) is the primary standard of treatment, however, access to MOUD and prenatal
care is limited, siloed, and fragmented in Florida. Gaps in access to and continuity of healthcare (prenatal,
postpartum, pediatric, pharmacological and behavioral health) and other services for mothers in OUD recovery
lead to poor outcomes for parent, child and family. There is also insufficient data integration, due to
inconsistent data collection methods or use of diagnostic codes, to identify mother-infant dyads affected by
OUD that could inform optimal care at the local level. Single-site studies that integrate substance use disorder
programs in pregnancy have been shown to improve neonatal and maternal outcomes. With that in mind, the
long-term goal of this study is to leverage high-quality local and timely data to improve OUD outcomes before,
during, and after pregnancy with an integrated care approach that can be replicated throughout the state. The
objective of the proposed project is to consolidate multiple streams of public health and clinical healthcare data
to analyze equitable access and outcomes for families affected by maternal OUD for use in quality
improvement cycles to rapidly refine our integrated CADENCE (Continuous and Data-Driven Care) Program.
Our central hypothesis is that integrated, continuous, data-driven care will improve CADENCE patient
outcomes. We will test this hypothesis through the following aims: 1) create an interactive data dashboard for
maternal, neonatal, and infant outcomes for pregnancies affected by OUD; 2) pilot the CADENCE program and
rapidly refine using a data-driven approach; 3) determine the improvement in clinical outcomes at the program
level using the data from the dashboard and assess the implementation of the CADENCE program; 3) analyze
the cost of the CADENCE program and long-term costs of maintenance of the program. Upon completion of
our aims, the expected outcomes include improve maternal, neonatal, and infant outcomes using an integrated
care model and data-driven approach to tailor services to community and patient needs. Primary outcomes
increase in maternal engagement in recovery or MOUD treatment at delivery, neonates with NOWS (neonatal
withdrawal syndrome) requiring pharmacologic treatment at delivery, and infant’s age at referral to the Early
Steps early intervention program. Our proposed plan is innovative as it is grounded in systems thinking, uses
population-level and integrated clinical data to develop a dashboard methodology, and addresses an area of
medicine with few previously published efficacy studies. This project meets the goals of the NIH as it aims to
decrease racial inequities in prenatal care and increase access to prenatal care to decrease maternal and child
mortality and morbidity.

Public health relevance
NARRATIVE The proposed project is relevant to public health and to the NIH because it seeks to use public health and clinical data on opioid use disorders (OUD) outcomes for mothers and infants, which is the leading cause of death to mothers one year after deliver and can lead to neonatal withdrawal syndrome (NOWS) and other poor outcomes. Insufficient or incomplete data about OUD and lack of integrated programs for OUD treatment during pregnancy can be barriers to providing optimal care to mothers and infants. Completion of this project is a first step toward creating a data dashboard development methodology that can inform continuous prenatal, maternal, and infant care in other communities.